ShEEP-IC: Request for Flow Cytometer

The requested instrument is a Flow Cytometer (model: LSRFortessa) manufactured by BD Biosciences. This flow cytometer analyzer features 4 lasers (Blue 488 nM, Red 640 nM, Violet 405 nM, and UV355 nM) with the capacity of 6 blue, 4 red, 6 violet and 2 UV detector colors. It can analyze more than 10 proteins in the same cell at the same time. Therefore, it is a state of the art instrument. This instrument will support at least 6 VA funded research projects from 5 VA Principal Investigator: 1): 5I01BX001962, Function of verticillin A in suppression of MDSCs and CRC stem cells (PI: Dr. Kebin Liu); 2) 5I01CX001357: Epidermal aquaporin-3 in psoriasis PI: Dr. Wendy Bollag); 3) 5I01BX001344, Regulation of aldosterone production in the adrenal (PI: Dr. Wendy Bollag); 4) 5101BX001517, Role of chemokine receptor CXCR7 in prostate cancer progression (PI: Dr. Balakrishna Lokeshwar); 5) 1I01RX001613, GPR109A and Parkinson's Disease: Role of Niacin in Outcome Measures (PI: Dr. Chandramohan Wakader); and 6) 5I01BX002035, Airway and lung vascular remodeling in COPD (PI: Dr. Yunchao Su). It is expected that this shared instrument will increase research productivity and promote collaborations between VA-funded Investigators to advance VA mission.

Public health relevance
The acquisition of this Flow Cytometer to our Core Laboratory Services will promote collaborations between VA-funded Investigators, increase research productivity of VA-funded research projects and advance VA mission to improve Veterans health through research and discovery. Having this equipment on station will reduce the need to submit partial off site waiver requests for flow cytometry services.